Metabolic, behavioral and social determinants of youth-onset T2D

ABSTRACT
Youth-onset type 2 diabetes (YT2D) has emerged as one of the most important clinical and public health
consequences of the current obesity epidemic. Not only have the rates of YT2D been increasing over the
years, achieving and maintaining optimal glycemic control in this population poses unique challenges.
Furthermore, disease progression in youth is faster than in adults, with a higher risk of developing diabetes
complications earlier in the disease process than adults. Importantly, there are profound disparities in the
burden of YT2D, with racial/ethnic minorities the most at risk. Despite these facts, the pathophysiology that
leads to the development of YT2D is not well understood and even less is known about the social determinants
of health (SDOH) associated with YT2D risk. Given that SDOH are major drivers of disease among
racial/ethnic minorities, there is a critical need to assess the intersection of SDOH and biological factors in
shaping the risk of developing YT2D. In response to RFA-DK-21-002, we propose to establish a cohort of
children at risk of YT2D by recruiting from the Children’s Hospital at Montefiore Medical Center (CHAM)
pediatric primary care practices (the largest provider of children’s health services in the Bronx). The Bronx is
one of the most racially and ethnically diverse counties in the country; children in the Bronx have a high burden
of obesity-related metabolic disorders and of social and economic adversities (e.g. food insecurity). Thus, our
site is very well positioned to contribute to a better understanding of the factors that lead to inequities in YT2D
risk and to inform development of more effective prevention and glycemic control strategies. Our overall
objectives are to: (1) Develop more precise and clinically feasible prediction of which individuals are truly at risk
for developing YT2D, by assessing the combined impact of metabolic and lifestyle factors, socio-economic
status (SES), sociocultural factors, and other SDoH; (2) Increase understanding of the physiologic drivers of
YT2D; (3) Provide a platform and supportive infrastructure for in-depth ancillary studies on critical aspects
related to YT2D using cohort data and banked specimens

Public health relevance
Project Narrative This study will contribute to identify the main risk factors that put children at risk of developing YT2D. The study will shed light on the factors that explain health disparities in YT2D.